Twelfth International Conference on the Chemistry and Biology of Mineralized Tissues

PROJECT SUMMARY/ABSTRACT The purpose of this application is to obtain partial support for the upcoming Twelfth International Conference on the Chemistry and Biology of Mineralized Tissues (12th ICCBMT) on May 28-June1, in Potsdam, Germany. More than 65% of our requested support is targeted to young investigator travel awards. This meeting is a forum to share the newest research advances on the structure, function, and interactions of the mineral, extracellular matrix, and cellular components in invertebrates and vertebrates in tissues such as shells, bone, cartilage and tooth while encouraging communication and collaboration among attendees from clinical and basic science disciplines. Specific aims are to: 1. Assemble a multidisciplinary and diverse group of scientists with a common interest in biomineralization; 2. Disseminate state-of-the-art cross-discipline information about the structure, function, and interactions of the mineral, matrix and cellular components in vertebrate and invertebrate tissues; 3. Provide a forum that fosters collaborations among investigators across diverse scientific disciplines in biomineralization; 4. Support participation and mentoring of junior investigators and student trainees though Travel Awards and forums, providing these individuals a platform to present their work, interact with senior investigators and obtain knowledge on career development and funding opportunities; and 5. Communicate the ascertained knowledge through a published ICCBMT meeting proceedings in a peer-reviewed journal, broadening the access of important findings to other scientists and clinicians. These outcomes will foster the basic mission of the NIDCR & NIAMS by providing new knowledge to improve the skeletal health of our nation through high quality novel research, by facilitation of interactions and collaborations of scientists across multiple fields related to mineralization, by providing networking and training to junior scientists and students in the field, and by broad open dissemination of the meeting’s findings.

Public health relevance
PROJECT NARRATIVE The purpose of this application is to obtain partial support for the Twelfth International Conference on the Chemistry and Biology of Mineralized Tissues (12th ICCBMT) being held May 28 - June 1, 2017, to provide new knowledge to improve the health of mineralized tissues throughout our nation through high quality research, to facilitate discussion and collaborations among a group of national and international scientists across multiple fields related to mineralization, to provide networking and mentoring to junior scientists and students in the field, and to disseminate the meetings’ science knowledge gained through a peer-reviewed publication.